CRCNS: Using Perturbations and Modeling to Study Connectivity for Decision-Making

Much work over the past decades has identified brain areas that are necessary for decision-making and
neural activity patterns that correlate with decision-making computations. These findings have inspired
computational models that propose greatly differing computations (e.g., competition, amplification, and
stabilization) for how the same cortical circuits contribute to decision-making, and thus distinct underlying
connectivity mechanisms. While much experimental work has tested and refined these models, from
neural activity measurements alone, it often remains unclear if a brain area generates its decision-related
activity patterns, and how it might generate them, or merely inherits them from another brain area.
Ultimately, a direct measure of the connectivity motifs, and the computations they perform, is needed to
identify what and how cortical circuits contribute to decision-making. Here, we propose to use
cellular-resolution optogenetics to measure a circuit's effective connectivity by perturbing small groups of
neurons while measuring the effect on neural activity in surrounding neurons. In the first aim, we will
measure the effective connectivity between excitatory and inhibitory neurons with identified activity
patterns during a decision task in virtual reality. In the second aim, we will develop and test multiple
classes of computational models in conjunction with the experimental results. We aim to discover the
connectivity motifs that exist in cortex and reveal the decision-related computations that are performed by
these motifs. We hypothesize that recurrent connections amplify choice selectivity through competition
motifs mediated by inhibitory neurons and create choice-informative sequences of neural activity through
inhibitory control of activity timing. We thus predict that inhibitory neurons play a critical role in these
computations by having sharp choice selectivity and precise connectivity profiles.
RELEVANCE (See instructions):
The proposed work will reveal fundamental mechanisms of neural function for decision-making. The new
methods, models, and concepts will provide a foundation to understand how decision-making is disrupted
in neurological disorders and diseases.